Dissecting the Forward Trafficking of Presynaptic Voltage Gated Calcium Channels

ABSTRACT
Voltage-gated calcium channels (CaVs) are indispensable components of the presynaptic active zone because
they directly drive synaptic transmission. However, the expression of CaVs within the presynaptic terminal
presents a considerable trafficking dilemma. Presynaptic CaVs are synthesized at the cell body where they are
often separated from their final destinations by hundreds of millimeters. CaVs en route to the presynaptic terminal
must therefore navigate multiple trafficking checkpoints that restrict passage of misdirected cargoes including
export from the Golgi apparatus, entry into the axon compartment, cargo capture at presynaptic terminals, and
finally anchoring within the active zone. Further, all neuronal CaVs exhibit a significant degree of sequence and
structural homology, including those that sort exclusively into somatic and dendritic compartments. In
consequence, the mechanistic pathways that target CaVs specifically to the presynaptic terminals remain
obscure, despite their central importance to neuronal activity.
In this proposal I will focus on dissecting the trafficking of CaV2.1s, a major presynaptic CaV isoform. Recent
studies have established the CaV2.1 C-terminus as a critical locus of targeting sequences. In addition to motifs
that tether CaV2.1s to the active zone scaffold, my preliminary data reveals that the proximal region of the CaV2.1
C-terminus contains key sequences that are together necessary for presynaptic expression. Further, I show the
compartment targeting of CaVs is determined primarily by its C-terminal sequences. I therefore hypothesize
that the CaV2.1 proximal C-terminus is a key determinant for CaV2.1 active zone targeting and function. I
will test this hypothesis through two specific aims. In aim 1, I will identify the trafficking checkpoints that require
the proximal C-terminus. My preliminary data establish that mutations within the proximal C-terminus abolish
presynaptic localization of CaV2.1s. My goal is to identify the specific trafficking checkpoint that is disrupted. I
will evaluate how proximal C-terminus mutations affect the Golgi export, axon targeting, presynaptic capture,
and active zone anchoring of CaV2.1 cargoes by visualizing CaV2.1s in the somas and axons of neurons and at
the plasma membrane in cell lines. In aim 2, I will define the minimal CaV2.1 sequences for active zone
localization and function. In preliminary experiments, I show that the transfer of key targeting sequences from
CaV2.1 to CaV1 can redirect these channels from the soma and dendrites to the presynaptic active zone. I will
generate further chimeric CaVs to isolate the trafficking functions of individual CaV2.1 sequences. I will
comprehensively probe for rescue of synaptic transmission in neurons that re-express CaV chimeras by means
STED microscopy, calcium imaging and electrophysiology. In summary, this proposal addresses a fundamental
gap in our understanding of presynaptic CaV trafficking. The findings from these experiments will reveal novel
regulatory mechanisms in CaV trafficking and they may in turn inform healthcare of neuropathies that stem from
the aberrant expression and trafficking of presynaptic CaVs.

Public health relevance
PROJECT NARRATIVE The presynaptic voltage-gated calcium channel CaV2.1 drives synaptic transmission, however we lack fundamental understanding of the mechanisms that direct CaV2.1s to the presynaptic terminal. The CaV2.1 C- terminus has emerged as a major regulator of presynaptic CaV2.1 trafficking. This proposal aims to characterize the trafficking functions of key sequences within the CaV2.1 C-terminus, providing insight into the cellular mechanisms of synapse formation and maintenance and the treatment of neuropathies that stem from failures in calcium channel trafficking.